mitoNEET as a therapeutic target for mitigating ischemic brain injury following MCAO

PROJECT SUMMARY
Accumulating evidence suggests that following ischemic stroke hypoperfused brain tissue is functionally disabled
as electrical communication among penumbral neurons is disrupted due to marked reductions in oxidative
metabolism. Thus, it is apparent that mitochondrial dysfunction plays a central role in the degree of neuronal cell
death encountered following ischemic brain injury; however, mitochondria have been slow to be fully
investigated. Through a serendipitous discovery of an off-target therapeutic effect of pioglitazone, a small
mitochondrial iron-sulfur cluster protein, mitoNEET (mNT) was identified that has renewed interest in therapeutic
targeting of mitochondria. MitoNEET is embedded in the outer mitochondrial membrane and acts as a redox and
pH sensor to regulate mitochondrial bioenergetics, especially in response to cellular stress. Using pioglitazone
as our parent compound, we designed NL-1, a first-in-class ligand with high specificity for mN. Using NL-1, we
have demonstrated marked improvements in stroke neuropathology and functional impairment following
transient middle cerebral artery occlusion (MCAO) in mice and rats. The objective of this proposal is to address
fundamental gaps in knowledge regarding how mNT works within the brain to mitigate acute ischemic brain
injury. Our central hypothesis is that modulation of mNT acts to improve vulnerable neurons within the
penumbra by reducing the vicious cycle of excessive iron-induced lipid peroxidation and increased neuronal
death. Based on a strong body of prior literature and pilot data, we postulate the initial target of activity for NL-1
is the cerebral microvasculature; thus, we propose two specific aims to test our hypothesis. In specific aim 1,
we will test if mNT selective ligand, NL-1, mitigates ferroptosis using a 4 cell Transwell in vitro model of the blood-
brain barrier following oxygen-glucose deprivation with reperfusion. Whereas, in specific aim 2, we will test if
mNT ligand, NL-1, reduces brain iron accumulation and blood-brain barrier dysfunction post-MCAO. Successful
completion of the proposed research is expected to provide a: (1) greater understanding of how & where mNT
mitigates brain injury following ischemic stroke; (2) new insight into the impact of mitochondrial dysfunction &
diminished bioenergetics on ischemic stroke outcomes; & (3) strong scientific foundation for an interventional
therapeutic approach for treating ischemic stroke. The mechanistic & preclinical data obtained through these
studies will serve as critical milestones for advancing the development of mitochondria-targeted therapies for
treating neurological injuries & disease.

Public health relevance
PROGRAM NARRATIVE The proposed research is relevant to public health as an urgent medical need exists to develop novel therapeutics to improve post-stroke recovery by mitigating the severity of ischemic brain damage. A unique therapeutic target, mitoNEET, has been identified and a novel tool, NL-1, has been developed to gain a better understanding of how mitoNEET modulation reduces stroke neuropathology and improves functional outcomes in aged male and female rats following MCAO. The proposed research is relevant to the missions of the NIA and NINDS by conducting basic science research aimed at improving the devastating effects caused by acute ischemic stroke and is relevant to the NIH by improving health by developing a library of compounds that can be employed as tools, probes and possibly therapeutics that will improve health through innovative research.